A Population-Based Latinx Community Study of Alzheimer’s Disease

ABSTRACT
Older Latinx adults in the US are at a greater risk of developing Alzheimer's disease (AD) and related
dementias (ADRD). They exhibit a faster cognitive decline than non-Hispanic whites. However, they remain
vastly underrepresented in research studies to characterize risk factors associated with progressive cognitive
decline. A better understanding of risk factors can provide better treatment and design appropriate preventive
strategies for older Latinx adults. Since older Latinx adults have a higher prevalence of cardiovascular risk
factors, their risk of developing ADRD is high in old age. Older Latinx communities were disproportionately
affected by the COVID-19 pandemic, which can increase their risk for neurological disorders. This UH2/UH3
cooperative agreement aims to engage and develop the infrastructure for a new Latinx cohort study with the
following aims: (1) build infrastructure, community outreach, and the external advisory board for a new Latinx
cohort; (2) develop ongoing engagement with the community and resource sharing plan; (3) collect data on
250 Latinx participants from East Side sampling frame; and (4) test the exploratory hypotheses that Latinx
participants have a higher prevalence of clinically diagnosed AD and MCI, and the impact of COVID-19 on AD
is more severe compared to non-Hispanic whites, and the ApoE4 association with clinical AD and MCI is the
same as NHW. The long-term objective is to perform a sizeable muti-ethnic study, combining the Latinx cohort
with our existing Chicago Health and Aging Project (CHAP), a population-based community study in four
neighborhoods with 10,801 participants with 63% non-Hispanic Black and 37% non-Hispanic white
participants. This UH2/UH3 proposal will add a new Latinx cohort in the East Side community of Chicago, with
over 60% Latinx. A multi-ethnic cohort will allow us to test several biological and psychosocial hypotheses of
high public health significance. The collection of biospecimens will also allow for testing further blood
biomarker hypotheses, developing an omics pipeline down the road, and providing additional infrastructure for
pathology studies in a population-based cohort study with minorities.

Public health relevance
The population of the US is aging rapidly, with considerable growth in Latinx older adults. The increase in the minority population will tremendously impact the public health systems. Understanding the determinants of health in the Latinx population and contrasting them to other racial/ethnic groups will provide better preventive strategies for the Latinx minorities and help lessen the growing Alzheimer's and dementia epidemic in the US.